In vitro myelination assay modeling the environment of MS lesions for predictive discovery of remyelinating therapies.

Project Summary
Artificial Axon Labs Inc. (AAL), an MIT spinout, is developing a transformative drug screening platform, Artificial
Axons, to discover first-in-class remyelinating therapies for currently incurable myelin diseases, with the primary
focus on multiple sclerosis (MS). Current disease modifying therapies for MS prevent the formation of new
inflammatory lesions in the central nervous system (CNS), but the majority of prior lesions fail to remyelinate and
there are no clinically available therapies to promote remyelination and prevent neurodegeneration. One of the
major roadblocks in the discovery of remyelinating drugs is the lack of biomimetic drug screening tools that can
quantify myelination in response to screened compounds, and do it in the conditions that mimic the environment
of demyelinating MS lesions, which often contain factors that inhibit myelin repair. Assays based on tissues or
co-cultures of neurons with oligodendrocytes are too complex for effective drug screening. Current screening
methods typically rely on 2-dimensional assays that can only evaluate compounds’ potential to stimulate
differentiation of oligodendrocytes (myelinating cells in the CNS), but not an actual process of myelin wrapping,
which requires 3-dimensional axon-like structures. Existing in vitro 3D myelination assays such as glass cones
or electrospun fibers are made of materials several orders of magnitude stiffer than the nervous tissue, and
therefore provide unphysiological environment to myelinating cells. As the result, remyelinating drug candidates
discovered with these insufficient tools so far have limited success in the clinic.
To address this urgent need, AAL is developing Artificial Axons, a novel biomimetic 3D-printed drug discovery
platform for remyelinating compounds. Unlike any other platform, our platform enables remyelinating drug
screening by direct visualization and quantification of myelin wrapping in response to compounds in the MS
lesion-like environment. We create this environment by combining 3D-printed axon mimics, matching the
geometry and low mechanical stiffness of biological axons, with key pro-inflammatory soluble factors, which
inhibit myelination in MS lesions (interferon gamma and myelin debris). These critical advantages over existing
assays make our platform a superior tool for the discovery of remyelinating compounds. In this project we focus
on two milestones: 1) developing a myelination assay, which includes common inflammatory factors that inhibit
myelin repair in MS lesions (interferon gamma and myelin debris), and 2) validating the new assay by testing
how the efficacy of known pro-myelinating compounds changes in the hostile environment of MS lesions.
Achieving these milestones will advance our technology on the path to commercialization and accelerate the
discovery of remyelinating treatments for MS and other myelin diseases.

Public health relevance
Project Narrative Artificial Axon Labs Inc. is developing a transformational drug screening platform to discover currently non- existing remyelinating therapies for incurable myelin diseases, with the focus on multiple sclerosis (MS). Although the disease modifying therapies for MS available today can prevent the formation of new inflammatory lesions, they do not stop the progression of neurodegeneration and disability in patients, because they fail to stimulate regeneration of myelin, a process called remyelination. To discover urgently needed remyelinating drugs, we developed entirely novel platform, where we use state-of-the art 3D printed artificial axons, very similar to real biological axons, to directly visualize and quantify myelination in response to compounds in the conditions similar to that in the MS brain. Our Artificial Axons platform provides entirely novel and powerful drug discovery tool, which can deliver remyelination drug candidates with a high therapeutic potential in MS patients.